The Upstream Center: Income Interventions to Address the Fundamental Causes of Cancer

Persistent poverty environments impose particular challenges for cancer prevention, with complex and intersecting factors creating barriers at the individual, health system, and population level. Improving cancer outcomes in these areas requires transformational, multisector solutions targeting social drivers of health, with research and policy development processes that are co-created with communities. To address this challenge, we will form the UPSTREAM Research Center, an innovative approach to the problem of income deprivation by leveraging state programs for Guaranteed Basic Income and the Earned Income Tax Credit (EITC). Our team science approach to this problem is supported by the unparalleled resources at Stanford University, the University of California, San Francisco and the University of California, Davis. Our work advances multiple conceptual and methodological innovations through two main research projects: 1) an ongoing partnership with the California Department of Social Services to access and evaluate a $35M intervention of Guaranteed Basic Income in persistent poverty areas with a focus on modifiable cancer risk factors and intermediate outcomes; 2) the impact of increases in income support through the EITC, which in California has a unique focus on lower income wage earners. Our Specific Aims are to: Aim 1. Build a collaborative community of residents in persistent poverty areas, policy makers, trainees, cancer and social science researchers and data scientists that co-create programs to address the impacts of poverty, Aim 2. Evaluate the impact of income-based interventions in persistent poverty areas in Northern CA, Aim 3. Develop a mathematical model, with community input, that can assist in predicting long-term impacts of income-focused interventions on cancer incidence, providing community members, policy makers, and researchers with guidance on how best to eliminate the increased burden of cancer in persistent poverty areas, Aim 4. Develop and implement a career enhancement program that will facilitate the training and career development of interdisciplinary early-career scholars who are committed to advancing cancer research in persistent poverty areas, and Aim 5. Implement innovative and collaborative cancer prevention and control programs identified through the UPSTREAM Research Center research projects and our community partners to develop long-term sustainable strategies in our Northern CA Catchment Areas and across the Persistent Poverty Centers Network. Results from this novel groundbreaking work will lay the foundation for transformative approaches to address cancer prevention and control programs in the face of severe economic and social hardship through capacity building and sustainable partnerships with policymakers, state and local agencies and community partners.

Public health relevance
Addressing a problem as daunting as persistent poverty and cancer requires approaches with a focus on changing the hazardous conditions in which people live, learn, work and play. The UPSTREAM Research Center, working with policy makers and community partners, will advance the science and practice of anti-poverty policies to prevent cancer in persistent poverty communities. Results from this work will lay the foundation for transformative approaches to address cancer prevention and control programs through capacity building and sustainable partnerships with policymakers, state and local agencies and community partners.